Optimizing a school-based obesity prevention intervention for adolescent girls

ABSTRACT
In Kenya, like most low- and middle-income countries (LMICs), rapid urbanization and changing food
environments are leading to increased access to energy-dense nutrient-poor foods that are contributing to rising
rates of obesity and the burden of nutrition-related noncommunicable diseases. Adolescence is a critical
lifecycle period for the prevention of obesity, and an opportunity to establish lifelong habits for healthy eating.
Adolescent girls are particularly at risk for overweight and obesity, and women in urban Kenya have more than
double the rates of obesity compared to men. Although there is widespread agreement on the need to improve
adolescent girls’ dietary practices in LMICs, effective obesity prevention interventions are lacking, particularly
in sub-Saharan Africa. With the mentorship and training proposed in this K01 application, I will pilot test theory-
based adolescent obesity prevention intervention components for girls in an urban informal settlement in Kenya.
In Aim 1, I will follow a community-engaged process to refine school-based adolescent obesity prevention
intervention components that were designed based on our previous formative research. In Aim 2, I will conduct
a pilot multiphase optimization strategy (MOST) study to determine the feasibility of recruitment, randomization,
intervention delivery, retention, and data collection procedures, and the acceptability of intervention
components in preparation for a future fully-powered factorial trial. In the pilot MOST study, 8 secondary schools
will be randomized to one of eight combinations of intervention components, and data will be collected from
students at baseline; after the 3-month intervention; and after a subsequent 3-month follow-up period. My aims
are linked to training objectives that will advance my conceptual knowledge and skills in obesity research, the
design of adolescent obesity prevention interventions, and MOST. This research will provide preliminary results
to inform a future trial testing a multicomponent adolescent obesity prevention intervention for girls in urban
Kenya. My mentoring team has expertise in the design of adolescent obesity prevention interventions, global
obesity research, and the design and analysis of MOST and factorial trials, as well as extensive experience
mentoring early career investigators. This research will generate novel insights into the design of school-based
adolescent obesity prevention interventions in urban LMIC settings. The K01 will help me achieve my long-term
career goal of becoming a leader in adolescent obesity prevention intervention research. With the support from
this award, I will transition from conducting intervention research focused on undernutrition to creating an
independent research program that is building the evidence base for effective obesity prevention interventions.
The proposed mentorship, training, and research activities will generate data needed to develop a competitive
R01 application to identify effective obesity prevention interventions for adolescent girls in urban areas.

Public health relevance
PROJECT NARRATIVE Rates of overweight and obesity among adolescent girls are increasing rapidly around the world, particularly in low- and middle-income countries, and there is an urgent need for evidence-based obesity prevention interventions for this population. This project will use a community-engaged process to refine and pilot school- based adolescent obesity prevention intervention components to improve the diets of adolescent girls in an urban informal settlement in Kenya. Adolescence is a critical time to establish healthy eating habits and prevent weight gain that can reduce the risk of chronic disease later in life.